The HOPE App Diversity Supplement: An Immersive Telehealth Solution for Older Adults with Diabetes

Project Abstract
Type 2 diabetes (T2DM) is an epidemic. An estimated 34 million people in the US have T2DM
and 84 million have pre-diabetes - nearly half of whom are adults 65+ yo, putting many older
adults at higher risk of unhealthy aging and cognitive decline. A healthy lifestyle can treat and
even reverse T2DM. But making lifestyle changes is hard and many people fail, contributing to
$327B in US healthcare costs. Diabetes group visits (DGV) and diabetes self- management
education and support (DSME/S) help people with T2DM to learn and sustain complex disease
management skills. Yet, access to DSME/S is limited such participation in DSME/S programs
is reportedly as low as 7% among adults with T2DM. New technologies supporting DSME/S
programs are emerging, but most fail to meet the unique needs of older adults with limited
technology fluency, creating a new digital divide. See Yourself Health (SYH) aims to bridge this
digital health gap for older adults with a newly designed immersive learning and telehealth
application – the HOPE App – designed to deliver high-impact, high engagement diabetes care
and DSME/S tailored for older adults with diabetes.
Advancements in virtual reality software, new cloud gaming technology and user interface
design have enabled our team to envision a new telehealth and immersive learning environment
to support chronic disease self-management needs of older adults with diabetes. We use virtual
reality, telecommunication technology and social gaming strategies to offer real-time peer
support, care coaching, and 28 modules of live-action experiential learning programs to help
participants master complex diabetes self-management skills. In our Phase I SBIR project, we
reached the following milestones: prototyped the HOPE App platform with cloud access and
new navigation and communication features; completed usability testing (SUS = 71) with 20
target users and feasibility testing (100% participation) of the HOPE App platform; developed
new DSME content for older adults. In Phase II, we will further develop the HOPE App patient
engagement and population health management features and capabilities and then assess its
efficacy in a fully powered clinical trial.
Specific Aim 1: Develop the HOPE App’s state-of-the-art immersive patient engagement
experience with automated onboarding, social networking and gamified DSME/S features to
support long-term patient retention.
Specific Aim 2: Develop the HOPE App’s predictive analytic capabilities for population health
management.
Specific Aim 3: Clinical validation of the HOPE App intervention on six-month clinical outcomes
(A1c), patient reported outcomes (diabetes distress) and engagement (patient retention,
adherence to DSME/S). SYH has assembled an expert business team to sell the HOPE APP to
our target customer, health care payors.
The HOPE APP offers a simple, high impact, highly engaging, immersive telehealth experience
with the potential to become a ubiquitous diabetes management tool to transform diabetes
patients into high performing drivers of their own care.

Public health relevance
Project Narrative Diabetes self-management education and support (DSME/S) helps people with T2DM learn and sustain healthy lifestyle behaviors and master complex disease management skills. Yet, only 7% of all adults with T2DM receive the DSME/S needed to effectively manage their diabetes care plan. New technologies supporting DSME/S programs are emerging, but most fail to meet the unique needs of older adults at high risk for unhealthy aging and cognitive decline related to poorly-controlled diabetes - creating a new digital divide. The See Yourself Health (SYH) team aims to bridge this digital health gap for older adults with the HOPE App, a new cloud-based immersive learning and telehealth program uniquely tailored for older adults with diabetes and clinically proven to maintain and improve cognitive and physical health.